Polypill strategy for the treatment of patients after acute coronary syndromes - A multicenter randomized controlled trial

PROJECT SUMMARY
Acute coronary syndrome (ACS) is common and a cause of significant morbidity and mortality worldwide. ACS
is treated routinely with percutaneous intervention followed by dual antiplatelet therapy and high-intensity lipid-
lowering statin therapy for 12 months. The post-ACS period is highly vulnerable, and rates of morbidity and
mortality remain high despite the availability of effective treatments. Non-adherence to post-discharge
medications is a major preventable cause of morbidity and mortality in the post-ACS period. Moreover, adverse
outcomes and non-adherence rates are higher among individuals from low-income groups and among
racial/ethnic minorities. The polypill strategy has shown promise in improving adherence to medications and
reducing cardiovascular risk in primary and secondary prevention settings. Nonetheless, polypill-based
strategies have not been evaluated for individuals in the vulnerable post-ACS period, when adherence to dual
antiplatelet therapy and high-intensity statins is particularly critical. Furthermore, optimal strategies for the
implementation of a polypill approach and its acceptance in the clinical community by different stakeholders
are not known. To address this knowledge gap, we propose a type 1 hybrid effectiveness-implementation,
multi-center, randomized trial to test the feasibility and effectiveness of a polypill-based strategy for post-ACS
management. We will utilize a flexible polypill containing a high-intensity statin, aspirin, and P2Y12 inhibitor.
The once-daily polypill will be added to baseline medical therapy. The primary endpoint will be composite
clinical outcomes, including all-cause mortality, ischemic events, and bleeding events over 12 months.
Additionally, we will evaluate the polypill acceptability, preferences, cost, and lessons among providers and
patients.

Public health relevance
PROJECT NARRATIVE Heart attacks are typically caused by a sudden coronary artery blockage from a blood clot. This can be treated by opening the blockage and placing a stent. Medications to lower cholesterol (statin) and blood thinners to prevent future clots (antiplatelet therapy) are prescribed to keep the blood vessels open and prevent another heart attack. These medications are crucial in the 12 months after a heart attack, and not taking them can result in another heart attack or death. We are conducting a randomized, multi-center trial to evaluate if a “polypill” that combines the necessary medications into one pill increases the use of these essential medications and reduces the overall risk of adverse clinical outcomes.